A Subunit Vaccine Against Acinetobacter Baumannii

Project Title: Development of a Novel Vaccine against Multi-Drug Resistant Acinetobacter baumannii
Abstract:
The escalating threat of Multi-Drug Resistant Acinetobacter baumannii (MDR-AB) represents a significant
challenge to global health, underscoring the urgent need for effective preventive measures. This SBIR Phase I
project aims to develop a novel vaccine candidate that stimulates immune protection against MDR-AB,
addressing a critical gap in our current arsenal against antibiotic-resistant infections. Leveraging a
multidisciplinary approach, our project integrates advanced immunological techniques, innovative vaccine
formulation strategies, and cutting-edge molecular biology tools. Phase I will focus on (1) identifying and
characterizing key immunogenic components of MDR-AB that lead to protective immunity, (2) developing a
prototype vaccine formulation, and (3) conducting preliminary in vitro and in vivo evaluations to assess
immunogenicity and protective efficacy. Employing a novel approach that enhances antigen selection, we aim
to select bacterial proteins that induce a strong and durable immune response. As MDR-AB continues to pose a
grave threat to public health, particularly in healthcare settings, the development of an effective vaccine is
imperative. Our project not only addresses this urgent need but also has the potential to significantly reduce the
incidence of MDR-AB infections, decrease reliance on antibiotics, and reduce the evolution of resistant strains.
Successful completion of this Phase I project will lay the groundwork for Phase II studies, including extensive
preclinical trials and the optimization of the vaccine formulation for clinical application.
Phase I Outcomes: Expected outcomes include the identification of optimal protective subunit candidates, the
establishment of a prototype vaccine formulation, and evidence of immunogenicity and efficacy in animal
models. These results will provide a solid foundation for further development and testing in subsequent phases,
moving us closer to a viable vaccine against MDR-AB.

Public health relevance
Project Narrative In the face of escalating antibiotic resistance, our research offers a transformative approach to combat the global health threat posed by Multi-Drug Resistant Acinetobacter baumannii (MDR-AB). Recognizing the critical gap in effective treatments against this formidable pathogen, we propose the development of an innovative vaccine to be generated using “differential reverse vaccinology” which can uniquely identify immune correlates from whole bacteria. This project not only addresses an urgent public health need but also sets the stage for groundbreaking advancements in the prevention of infections caused by antibiotic- resistant bacteria. By targeting a pathogen classified as a top priority by the WHO and CDC, our work is poised to significantly impact public health, offering a new paradigm in our battle against antibiotic resistance and saving countless lives worldwide.